Subcortico-Cortical Mechanisms of Sensorimotor Coordination, Integration, and Learning

Abstract
A long-term goal of my research is to develop a comprehensive understanding of the computational principles,
anatomical substrates, and neural mechanisms of sensorimotor function. Our research is guided by the concept
of internal models, which provides a unified computational framework for investigating the neural basis of
sensorimotor coordination, integration, and learning. Currently, we do not have a comprehensive understanding
of how the brain instantiates internal models. Our broad research objective in to elucidate the functional role of
the ascending cerebello-thalamocortical (Cb-Th-Ctx) and basal ganglia-thalamocortical (Bg-Th-Ctx) pathways
in forming, updating, and using internal models. We will tackle this problem in the nonhuman primate model
using a multidisciplinary and cutting-edge approach that leverages (1) a sensorimotor task with suitable variants
for investigating the neural basis of sensorimotor coordination, integration, and learning, (2) large-scale multi-
region electrophysiology techniques to characterize neural signals with high spatiotemporal resolution across
entire subcortico-cortical pathways, and (3) a mathematically rigorous framework to integrate knowledge across
scales (cells, circuits, areas) and disciplines (systems, computational), and link computational concepts (e.g.,
internal models) to directly measurable neurobiological variables (e.g., firing rates). In the next decade, we will
use this integrative approach to gain a mechanistic understanding of how Cb-Th-Ctx and Bg-Th-Ctx pathways
establish internal models and support adaptive sensorimotor behaviors.

Public health relevance
NARRATIVE Dysfunctions of sensorimotor behaviors are among the most common and devastating aspects of neurological disorders. Converging evidence from humans and animal models indicate that the cerebello-thalamocortical and basal ganglia-thalamocortico pathways play critical and complementary roles in sensorimotor behaviors. However, we do not have a coherent understanding of how these pathways support the basic building blocks of sensorimotor behavior including coordination, integration, and learning. In this proposal, we will combine large-scale multi-region electrophysiology and multi-region neural network modeling to tease apart the complementary roles of these pathways in sensorimotor behavior. This work will elucidate the computational principles, anatomical substrates, and physiological mechanisms of sensorimotor function, and promises to facilitate the development of diagnostics and treatments for victims of neurological disorders.